Characterization of a novel kin recognition system in mycobacteria

Distributive Conjugal Transfer (DCT) is a unique conjugation process, first described in Mycobacterium
smegmatis, which is so robust that it emulates the genome mixing capacity of sexual reproduction:
transconjugant genomes are mosaic blends of each parent. Thus, DCT is a new paradigm of conjugation,
evolution, and horizontal gene transfer (HGT)-mediated gene flow within a bacterial gene pool. Our long-
term goals are to elucidate the mechanism of DCT and understand its role in driving mycobacterial
evolution.
We recently defined a three-gene mating identity locus (mid) as critical for donor-recipient compatibility.
Remarkably, one gene within the locus, midA, confers mycobacterial self-identity (kin). If the identical
midA gene is expressed in both donor and recipient, DCT is prevented as the cells sense kin. The focus
of this proposal is to characterize this novel form of kin recognition in mycobacteria, and to determine
how it triggers/blocks DCT. Sequence comparisons of the three mid proteins in other mycobacteria shows
that they are highly polymorphic. We hypothesize that this sequence diversity is driven by the need to
express self-identity. MidA is predicted to have a small N-terminal cytoplasmic domain and a large
extracellular C-terminal domain. We propose a model in which direct cell contact between donor and
recipient would allow the interaction of the surface exposed MidA proteins to sense kin. The N-terminal
cytoplasmic domain would trigger a transcriptional response in the recipient that either activates (non-
kin) or prevents (kin) progression to conjugation.
The two Aims are designed to characterize the mycobacterial kin recognition protein(s), determine how
mid discriminates between contacting mycobacteria, and elucidate the molecular genetic pathways
triggered by mid.
Aim1. Define and characterize the mid locus and the encoded kin functions.
Aim 2. Identify and characterize the genes responsible for kin recognition in donor and recipient strains
by transcriptional profiling wild-type and mutant strains in co-culture.
These objectives will be achieved by employing a combination of molecular genetic, genomic, and
biochemical approaches to dissect the mid locus, and transcriptional profiling of donor and recipient
strains in coculture to determine the transcriptional responses to kin recognition and DCT. Together,
these studies will elucidate the molecular basis of kin recognition in mycobacteria and provide further
mechanistic insights on this novel mechanism of HGT.

Public health relevance
Project narrative. Mycobacterial diseases are a huge burden on global public health. There is a need to better understand the biology of mycobacteria. In this proposal, we will characterize a novel mechanism of chromosomal DNA transfer that has been described in both fast- and slow- growing mycobacteria and, we hypothesize, has played a major role in mycobacterial cell-cell communication and the evolution of mycobacterial pathogens.